Administration

Administrative Core
Summary
The NEIDL Administrative Core provides the leadership, organizational structure, and direction of an
established management plan that sustains the resources and infrastructure of the NEIDL at the highest level.
This enables us to meet our mandate as a member of NIAID’s national and regional biocontainment
laboratories network (the NBL-RBL network). It also ensures that we meet our mission to conduct cutting-edge
research in the pathogenesis of emerging infectious diseases, and support development of the next generation
of therapeutics, vaccines and diagnostics for emerging and remerging pathogens. The Administrative Core
Serves as the focal point for coordinating, supervising and supporting all of the activities of the NEIDL,
including all BSL-4 related activities. The specific aims of the core are to: 1. Coordinate and manage all NEIDL
administrative and scientific support activities, including the review process for scientific projects requiring
access to BSL-4 services and facilities; 2. Evaluate research progress and encourage data sharing, including
promotion of collaborations with local, national, and global scientific communities; 3. Provide a high level of
administrative support to optimize faculty and staff productivity, to ensure compliance with university
administrative requirements for faculty and staff, and to assist Core leaders with administrative aspects of their
Cores; 4. Ensure collaboration and coordination among core leaders, and communicate and interact with
NIAID staff. 5. Conduct administrative oversight and fiscal management of the NEIDL through an
organizational management structure, in particular to manage BSL-4 related NEIDL finances, including the
operation of cost-recovery activities for each of the Cores; and 6) Partner with NIAID and other federal
agencies in the management of all NEIDL BSL-4 facilities and operations, biosecurity, regulatory compliance,
specialized research support services, and training activities in support of the national biodefense research
agenda as needed.